Development of an automated healthcare system for effective management of patients with chronic diseases.

PROJECT SUMMARY
Care delivery at primary and urgent clinics is critically hindered by doctor shortage, time constraints and the
inappropriate use of infrastructures. The rising aging population and unhealthy lifestyle are expected to drive the
increase of chronic disease and the national health expenditures associated (20% of the U.S. gross domestic
product by 2025). Telemedicine has been proposed as a possible solution to reduce the cost of access to care
minimizing the dependence of patients on health professionals. However, current solutions that connect patients
with doctors don’t allow accurate diagnosis due to the lack or inappropriate use of medical devices. AdviNOW
proposes to implement computer vision to offer a clinically reliable approach to perform self- evaluation of vital
parameters. AdviNOW is developing the first Augmented Reality (AR) algorithms to guide any non-trained people
to correct usage of Class 2 medical devices at the point of need. The new approach will represent the core
component of a novel clinical decision support system (CDSS) which will be integrated into telemedicine
platforms, kiosks or any medical office to automate medical visits, improving the management of chronic
diseases. In Phase I, we validated the feasibility of our product by developing a module for heart stethoscope
exams. Users were able to autonomously take a phonocardiogram measurement in <8 seconds, while the
system verified the correct use of the device. In this Phase II project, the additional modules required for a
minimum viable product (MVP) with significant clinical and commercial impact will be developed. This will include
modules for Respiratory Auscultation, Otoscopic Ear Examination, Mouth Examination, and temperature control.
The developed modules will be then integrated within the current front-end structure. The MVP will be validated
in a clinical setting, where its usability, benefits, and clinical effectiveness will be assessed. Additionally, the
platform will be integrated with major providers of Electronic Health Records. At the end of this SBIR Phase II
project, an MVP ready to enter the market will have been fully developed. Future R&D efforts of AdviNOW
Medical will be aimed at the development of Artificial Intelligence based diagnosis of abnormal medical conditions
from self-measured biometric parameters. The mission of AdviNOW Medical is to develop a disruptive solution
for the delivery of healthcare that is safe, effective, timely, efficient, and available in centralized and decentralized
locations. By reducing the time for routine analysis, the actual doctor-patient encounter will be more meaningful,
improving the clinical outcome as well as patient satisfaction. This invention promises to disrupt healthcare, as
providers will improve cost management and profitability by visiting more patients.

Public health relevance
PROJECT NARRATIVE New strategies for accurate and efficient delivery of healthcare to chronic disease patients are required. This project will develop the first Augmented Reality (AR) algorithms which will guide patients to use Class II medical devices for self-assessment of vital parameters to monitor the health status of chronic conditions. The project is expected to introduce a novel clinical decision support system (CDSS) to Primary and Urgent care clinics and remote settings to allow improved medical outcomes and cost management of chronic diseases.